Regulating gut-brain homeostasis by vitamin B12 to resist stroke

Ischemic stroke is one of the leading causes of death in the United States and is a major culprit for eliciting
critical disability in veterans whereby the subsequent ailments can result in traumatic brain injury, potentially
manifesting in severe neurodegenerations. No efficacious therapy is currently available to translate into clinical
settings. We conspicuously demonstrated that stroke-induced inflammation deteriorated ileal epithelium
homeostasis and gut dysbiosis. Stroke also critically reduced regulatory T cells (Tregs) and significantly recruited
pathogenic IL17 gd T cells implicated in tissue damage. Intriguingly, vitamin B12 (VB12) functionally sustained
ileal epithelia cells (iECs), Tregs and microglia to synergistically protect against pathological inflammation. Thus,
controlling stroke-induced inflammation through VB12-dependent intervention may constitute a critical
therapeutic regimen to mitigate toxic inflammation and improve the host recovery. To investigate these
dovetailing lines of inquiry, the objective of the proposed studies is to mechanistically elucidate VB12 interplay
in functionally rewiring iECs, Tregs and the microbiome to synergistically control stroke-associated intestinal and
neuroinflammation, potentially improving host neurobehavior poststroke. The hypothesis is that VB12
molecularly coordinates the intestinal and cerebral cellular homeostasis to crucially limit stroke-associated
inflammation and significantly contributes to swift host recovery. The specific aims are: 1) Elucidate VB12-
dependent regulation of iECs during stroke-induced inflammation, 2) Delineate VB12 significance in functionally
sustaining ileal Tregs to control gut homeostatic response to induced stroke, and 3) Elaborate on VB12 interplay
in supporting brain Tregs to limit stroke-associated neuroinflammation and improve the host recovery thereafter.
The predicted outcomes of these preclinical studies will underscore VB12-dependet mechanisms involved in
alleviating and improving the host recovery post stroke.

Public health relevance
U.S veterans are particularly affected by high rates of stroke and are a greater representation of demographic groups most susceptible to stroke.1 While antidepressants potentially improve post-stroke neurologic outcomes, identifying new therapeutic targets, centered on microbiome-dependent micronutrients represents a new concept. Accordingly, our preclinical studies will uncover the impact of stroke-associated inflammation that induces profound changes in ileal epithelial cells (iECs), gut microbiome and the associated metabolites along with local and central toxic neuroinflammation. Therefore, we will further investigate the relevance of VB12, as a critical micronutrient, in potentially alleviating the risks of ischemic stroke-induced intestinal and neuroinflammation, secondary brain injury and the consequences thereafter. Obtained results may mechanistically contribute to improved therapeutic intervention to further advance stroke care through sustainable dietary regimens.